Providing New Insight Into Adolescent Dendritic Development

Project Summary/Abstract.
The extent of a neuron’s dendritic arbor plays a critical role in the processing of sensory information in
mammalian neocortex. Dendrites grow rapidly after birth and then exhibit an apparent stability during
adolescence and adulthood resulting from a dynamic, homeostatic balance of opposing growth and retraction
pathways. Disruption of this balance could induce structural changes in previously formed dendritic arbors,
leading to deficits in cortical dendritic architecture which characterize several adolescent-onset neuropsychiatric
disorders. Many of the factors controlling dendritic growth and regression in adolescence remain unknown,
creating a critical gap in knowledge regarding both normal and abnormal adolescent dendritic development.
We recently identified that Oligodendrocyte Myelin Glycoprotein (OMGp) in can induce dendritic regression, via
a Kalirin-9 (KAL9) dependent mechanism. OMGp expression increases naturally across adolescence,
suggesting it contributes to the apparent dendritic stability in adolescence by counterbalancing growth signals.
In support of this interpretation, we observed that a gain of function (GOF) in OMGp signaling (ie KAL9-PT)
induces adolescent-onset dendritic regression in Layer 3 pyramidal cells (PCs) in primary auditory cortex in vivo.
In addition to the shape of its dendritic arbor, the extent of a PC’s output is determined through tight control of
dendritic postsynaptic integration by inhibitory somatostatin (SST) neurons. Inhibitory synapses from SST cells
targeting the dendrites of Layer 2/3 PCs in primary sensory cortex are highly dynamic even into adulthood, and
therefore may remain susceptible to adolescent-onset changes in dendritic architecture. This proposal seeks to
test the overall hypothesis that OMGp is a critical regulator of normal dendritic development in adolescence and
increased activity downstream of OMGp leads to dendritic regression with resultant functional impairments in
SST-dependent intracortical sensory processing. We will test this hypothesis in a set of integrated Aims. Aim 1
will induce oligodendrocyte- and neuronal-specific OMGp KO at timepoints spanning adolescence to examine
the role of cell-type specific OMGp in maintaining cortical dendritic architecture stability. Aim 2 will identify the
functional consequences of adolescent-onset dendritic regression on cortical signal processing, using a highly
translational auditory stimulation paradigm and chemicogenetic suppression to evaluate the impact on SST-
dependent (and as a comparator parvalbumin (PV)-dependent) cortical processing.
Completion of these studies will serve to increase basic knowledge of dendrite development and cortical
refinement during adolescence, and how OMGp influences these processes.

Public health relevance
Project Narrative Following rapid growth early in development, dendritic arbors achieve apparent stability in size across adolescence but continue to undergo refinements that ultimately lead to dendrite- mediated signal selectivity and mature cortical circuits. This developmental epoch is a period of vulnerability for the onset of multiple neuropsychiatric diseases, yet the underlying mechanisms governing this crucial refinement remain incompletely understood. This project seeks to identify the role of OMGp in adolescent dendritic development, specifically integrating studies spanning anatomical and functional characterization, to better link dendrites to circuits to physiology.